Core--Immunohistopathology

DESCRIPTION (adapted from investigator's abstract): The Immunohistopathology Core C will provide coordinated and efficient facilities to allow reproducible and predictable histochemical processing of tissue samples that will be subsequently analyzed by automated or semiautomated image analysis techniques. The co-principal investigators will supervise a team that has an established record in quantitative tissue morphometrics, cell counting, immunohistopathology, in situ hybridization, gel analysis, and autoradiography. Accuracy and reproducible outcomes are likely to result from the approach. The co-principal investigators and staff will provide oversight for the facility including scheduling, training of project personnel, and supervising use of the image analysis facilities. The enhanced analysis system that will be used in this proposal is unique in that it replaces a variety of less sensitive, cumbersome technologies that have previously been used for this purpose. Technical personnel in the facility will all be well versed in the employment of the hardware and software in the proposed imaging center, as it applies to immunopathology, densitometry, and fluorescent techniques. The additional technician requested will provide support to Projects 2-4.